California Department of Food and Agriculture AFRPS LFFM Compliance and Enforcement Expansion Supplement

Project Summary/Abstract
The California Department of Food and Agriculture (CDFA) works to ensure the safety
of the food and feed supply through effective prevention, intervention, and response
programs. Within CDFA, the Commercial Feed Regulatory Program (CFRP) is
responsible for the enforcement of California state law and regulations pertaining to the
manufacturing, distribution and labeling of commercial livestock feed while preventing
adulterated feed from being consumed by livestock. The CFRP works to ensure a clean
and wholesome supply of meat, milk, and eggs, as well as to provide assurance that the
product received by the consumer is of the quality and quantity purported by the
manufacturer.
CFRP has partnered with the California Animal Health and Food Safety Laboratory
System (CAHFS) to obtain samples in support of their Laboratory Flexible Funding
Model (LFFM) cooperative agreement with the U.S. Food and Drug Administration
(FDA). The proposed project requests funding to offset the cost of CFRP’s activities in
support of the LFFM, including the development of a joint LFFM sample plan, LFFM
sample collection for the hazard-commodity pairs identified, enforcement follow up on
violative LFFM samples, and participation in IT-data exchange development and
implementation as directed by FDA. Follow up on violative LFFM samples will include
notification/coordination with FDA and other appropriate agencies for samples outside
CFRP’s regulatory authority/jurisdiction. Activities under the proposed project may also
contribute to the identification of gaps in existing procedures developed under the
Animal Feed Regulatory Program Standards (AFRPS) cooperative agreement.
Participation in the AFRPS has allowed CFRP to strengthen its already robust training,
inspection, auditing, emergency response, enforcement, outreach, and sampling
programs, implement program evaluation measures, and begin building capacity to
conduct comprehensive Food Safety Modernization Act inspections. CFRP is seeking
$100,000 in cooperative agreement funds to support enhanced collaboration with
CAHFS and FDA in support of the LFFM, including application of the AFRPS framework
and regulatory/compliance response for violative LFFM samples.

Public health relevance
Project Narrative The goal of the proposed project is to support the California Department of Food and Agriculture (CDFA) Commercial Feed Regulatory Program (CFRP) in sampling and enforcement efforts for samples taken for the California Animal Health and Food Safety (CAHFS) laboratory's lab flexible funding model (LFFM) cooperative agreement while enhancing information sharing and coordination with the Food and Drug Administration (FDA) and other state partners. CFRP will apply the inspection, sampling, and regulatory framework of our existing Animal Feed Regulatory Program Standards (AFRPS) procedures and ensure adequate personnel to adhere to the CAHFS lab’s LFFM sample plan. If a violative sample is found, CFRP will apply the enforcement, response, and regulatory AFRPS framework while maintaining communication with the Food and Drug Administration (FDA) and other agencies, as appropriate for violations outside CFRP’s regulatory authority/jurisdiction.